Distinct molecular profile and function of pioneer and follower neurons

Project Summary
During development, axon growth is initiated by specialized types of neurons called “pioneer neurons”. As their
name implies, they are the first to explore the dynamic environment of a developing tissue. After pioneer neurons
extend their axons toward a particular target, their axon tracts act as a scaffold for the subsequent axon extension
of other neurons, termed “followers”. Pioneer neurons have been well documented in the central and peripheral
nervous systems of both vertebrates and invertebrates, but whether their molecular make up is distinct from that
of followers is not known. We have recently shown that the neurotrophic factor receptor ret is specifically enriched
in sensory pioneer neurons of the zebrafish, suggesting pioneer and follower neurons have different
transcriptional profiles. To test this hypothesis, we conducted single-cell-RNA-sequencing (scRNA-seq) of these
sensory neurons. Our scRNA-seq demonstrated that ret+ neurons indeed have a distinct transcriptional profile
from ret- neurons. Expression analysis revealed 101 differentially expressed (DE) genes between these two
populations. Furthermore, single molecule in situ hybridization of DE genes confirmed the presence of two
distinct neuronal populations in vivo. To demonstrate that the presumptive pioneer-specific cluster indeed marks
pioneer neurons, we knocked in a red fluorescent protein into rpz5 locus (rpz5 is almost exclusively expressed
in the ret+ cell population). The reporter labeled pioneer axon terminals, confirming the ret+ population indeed
represents pioneer neurons. We also discovered that a pioneer neuron “gene signature” is enriched in both
developing peripheral and central nervous systems. Thus, the pioneer cell state we discovered represents a
common feature in the nervous system. Based on this and additional preliminary data, we propose three specific
aims that will determine: 1) the lineage relationship between pioneers and followers and molecular signals that
specify pioneers; 2) the role of DE signaling pathways in differentiation of pioneers and followers; and 3) the
molecular basis of distinct physiological properties of pioneers and followers. The successful completion of these
aims will identify the mechanisms by which pioneer neurons arise and how they are specified. The core set of
cellular functions in pioneers is characteristic of many types of neurons, so the knowledge gleaned from these
studies will be relevant to pioneer neurons in other systems. Finally, identifying main factors regulating pioneer
neuron fate commitment will create a list of novel therapeutic targets for studies involving nerve injury and
regeneration.

Public health relevance
Project Narrative Pioneer neurons are a critical part of nervous system development and regeneration, as they are the first to extend axons into a new region, connect to the proper target cells, and act as a guide for “follower axons” to extend later. The core set of cellular functions in pioneers is characteristic of many types of neurons, so the knowledge gleaned from these studies will be relevant to pioneer neurons in other systems. Identifying main factors regulating pioneer neuron fate commitment will create a list of novel therapeutic targets for studies involving nerve injury and regeneration.